Nikon CSU W1 SoRa Super Resolution Spinning Disk Confocal Microscope with Photo-Stimulation and Photo-Ablation

Project Summary
This request is for a Nikon CSU-W1 SoRa super resolution (SoRa-SR) spinning disk confocal microscope
with photo-stimulation and photo-ablation capabilities. The long-term goal is to increase our research
productivity by obtaining higher quality and temporally resolved images at larger scales and high content (HC).
Our diverse projects, all funded by NIH, include identifying mitotic errors and genome instability, studying DNA
damage and repair signaling, investigating lysosome and mitochondria trafficking, examining chromatin
assembling and remodeling, understanding pain sensitization and hypersensitivity at the dendritic level, exploring
cytoskeleton dynamics involved in regeneration, cell extrusions, dendritic morphology and synapses formation,
and investigating reproductive tract, kidney and lung development. All these projects have high impact and
relevance to understand how cancer cells function and progress. The photo-stimulation module is required for
Fluorescence Recovery After Photo-Bleaching (FRAP) to study the dynamics of cytoskeleton and proteins
associated with promyelocytic leukemia protein nuclear bodies. The photoablation capability is required to study
linkage-specific ubiquitin conjugation at DNA damages sites, measure cellular tension by studying recoiling of
actin-myosin during pulsatile contractions, create gaps within the Mullerian duct to study reproductive tract
development, and to induce cell-cell contact damage to follow actin filament polymerization at forming adherens
junctions between nephron progenitor cells. The SoRa-SR is required to reveal synaptonemal complex
nanostructure inside chromatin, to visualize the apical and basal actin-myosin layers, which are important for
understating cellular extrusion, and to understand the spatial-localization of proteins involved in dendritic
arborization and synapse formation. The SoRa-SR will be also used in combination with HC-imaging to study
mitotic errors that lead to chromosomal instability and it will be needed by many other projects. The need for
live-imaging (short or long term) with optical sectioning combined with the ability to image larger fields of view
in 3D with low photo-bleaching and low photo-toxicity is essential to all these projects. Some projects need to
image large montages in 3D with HC. Other projects need to use multi-well formats to study cells under various
conditions (e. g. chemotherapeutic drugs). Our current spinning disk microscope system (CSU-X1), which is 13
years old, is currently limiting our projects. The proposed system would greatly benefit our research due to the
ability to image a wide range of sample thickness and the needs within our user group (11 Major & 4 Minor). It
would allow us to perform FRAP, live ratiometric FRET and ABLATION, besides performing high-resolution live
imaging, including thicker specimens. During a 10-day demonstration of the SoRa-SR system in our department,
our user’s needs were achieved and in some cases they observed events they had not previously seen. The
versatility of the proposed system will make a significant impact on our research, bringing our core up to date
with new technologies and allowing us to excel in our research at MD Anderson Cancer Center.

Public health relevance
Project Narrative Currently, a great majority of research projects that study mechanisms of diseases are dependent on microscopy techniques that allow them to look at the organization, localization and dynamic behavior of proteins inside cells, tissues and entire organisms to better understand how they affect and control human body health and disease. The microscopes utilized in research are extremely valuable and often get surpassed by technological improvements that can easily change the quality and speed of the research produced. The current request is to acquire a microscope called Nikon SoRa W1-spinning disk confocal with photo-stimulation and photo-ablation that will replace our obsolete 13 years old system with improved technology capable of producing higher quality and super-resolution (at 120 nm scale) live images that are essential for the comprehension of how cancer cells function and develop.